Heartland Cancer Research NCORP

The specific aims of the Heartland Cancer Research NCORP are to:
To be the primary vector for delivering, implementing, and executing NCI approved cancer treatment clinical trials;
cancer prevention, screening and control clinical trials; and Cancer Care Delivery Research clinical trials to a large
Midwestern rural and urban population;
Enhance Midwestern cancer care by providing convenient access for patients to a region-wide high standard of
multidisciplinary integrated cancer care delivery;
Participate in pilot studies for NCORP research bases and provide feedback on proposed trials.
Participate in NCI-sponsored tissue acquisition and biobanking studies, including those related to the Cancer Moonshot
initiative.
Reach out to underserved and vulnerable populations across Illinois and Missouri to improve access to cancer clinical
trials, state of the art care, and cancer prevention and early detection strategies;
Coordinate with local and state agencies to leverage resources to improve state wide cancer education regarding cancer
prevention, early detection, treatment and clinical trials;
Improve cancer prevention, treatment, screening, and survivorship education for healthcare professionals throughout
Illinois and Missouri. Educate healthcare providers across rural and urban Illinois and Missouri regarding cancer clinical
trials and incorporation of new findings into daily patient care.
Continue to recruit, train, and support new investigators and clinical research staff who share the vision and embrace
the objectives of the Heartland NCORP.
Explore and share best practices for improving the productivity of Heartland NCORP within an environment of limited
resources.

Public health relevance
The Heartland Cancer Research NCORP (Heartland NCORP) will be the premier community cancer research organization of the states of Illinois and Missouri by providing state of the art cancer clinical trials, cancer care delivery research, interdisciplinary cancer treatment planning, and coordinated biomarker driven research throughout our service region. Cancer patients, in specific, will benefit as a direct result of these clinical trials, and the consequential knowledge on preventing and treating malignancy in community settings will improve patient care.